VENOGLOBULIN R-S SAFETY AND EFFICACY IN PRIMARY IMMUNE DEFICIENCIES

This study will test the safety and efficacy of intravenous gammaglobulin compared to licensed gammaglobulins by assessing frequency of infections, time lost from school or work and evidence for adverse reactions. Half-life of the various gammaglobulins and the IgG subclasses will be determined.